Effects of spatial attention on neuronal circuits in the early visual system

The research proposed for this award will examine how spatial attention modulates cortical circuit activity in the eariy visual system. The proposed studies link the candidate's scientific bacl<ground and future career objectives by examining attentional modulation of neuronal activity at multiple processing stages. Attentional effects will be observed at the individual cellular level (Aim 1), the local circuit level (Aim 2), and the cortical population level (Aims 1 and 3). By employing this novel approach toward understanding attention within the context of cellular and circuit processing, the candidate will draw upon experience across all phases of her research career. The candidate is nearing completion of the mentored phase where she has received outstanding mentorship from her two co-sponsors and has greatly benefited from the resources available at the University of California, Davis. According to the experimental plan laid out in Aim 1, the candidate has sucessfully measured attentional modulafion of synaptic efficacy and cortical ensemble activily. The candidate has successfully implemented improvements in the attentional task and multi-neuron recording techniques which will greatly aid her transition and future success as an independent investigator. During the independent phase, the candidate will continue to address questions of functional dynamics in eariy visual cortical circuits using these improved spatial attention tasks and multi-electrode recording techniques. These experiments will further explore 1) whether and how the effects of spatial attention differ across neuronal cell types and local circuit levels, and 2) whether and how ongoing cortical network activity influences these attentional effects. All experiments proposed will be undertaken in the eariy visual system of awake-behaving monkeys, an ideal model for a number of reasons. First, while spatial attention influences eariy visual system activity, little is known about the mechanisms involved. Second, there is a wealth of knovifledge available about the primate visual system. Third, the awake-behaving animal paradigm allo\A¿ for the assessment of functionality in the fully cognizant state. Fourth, and most importantly, the primate visual systerti is similar to that of humans and therefore provides an ideal model for human cognition.

Public health relevance
Understanding the function of cortical circuits in the brain has Important implications for understanding, treating, and educating people with conditions of debilitating brain disorganization. Elucidating the mechanisms of visual attention at cellular and circuit levels will advance knowledge of human cognition allowing for improvements in disease prevention and treatment and in the quality of human life.